Dissecting the source and mechanisms of IL-17-mediated modulation of pancreatic tumorigenesis

Abstract
The incidence of pancreatic adenocarcinoma (PDAC) is steadily increasing while most treatment modalities
remain ineffective. Therefore, it would not be a surprise to learn that PDAC is one of the top-4 causes of cancer-
related mortality. What is most striking about this malignancy is that even if detected at early stages, outcomes
remain poor. It is well known that pancreatic cancer is characterized by an immunosuppressive environment,
already found surrounding premalignant lesions or pancreatic intraepithelial neoplasia (PanIN), which has been
postulated as one of the main reasons for the lack of response to most therapies. However, the regulatory signals
that precede and support the development of this suppressive TME are not well characterized. The objective of
this grant is to characterize the mechanisms and regulators implicated in the generation of the
immunosuppressive TME that characterizes pancreatic tumorigenic process and to reverse it through
pharmacological and microbial interventions. Our laboratory found that IL-17-secreting immune cells play an
important role in promoting pancreatic tumorigenesis in genetically engineered mouse (GEMM) models of
pancreatic cancer. We now plan to characterize the mechanisms by which IL-17 promotes tumorigenesis by
genetically deleting the IL-17 receptor specifically from the pancreatic oncogenic epithelium using GEMM and
CRISPR/Cas9 (Aim 1). We also found that IL-17 neutralization decreases recruitment of myeloid cells, mostly
neutrophils, and induces CD8+T cells activation and in PDAC orthotopic model. Monoclonal antibodies against
IL-17 or neutrophils will be used to assess the mechanisms employed by IL-17 supporting an
immunosuppressive TME (Aim 2). Finally, we have recently found that fecal microbial transplants can modulate
tumors systemically. In particular, human PDAC-associated gut bacteria is capable of increasing IL-17 levels in
circulation, which may affect distant tumors like pancreatic cancer. We now plan to definitively address the role
gut bacteria in promoting Th17 differentiation and its systemic implications by performing human-into-mice fecal
microbial transplants (Aim 3). Achieving our goals will not only help us better understand immunological as well
as microbial mechanisms implicated in pancreatic tumorigenesis, but will also result in practical novel
interventions with either monoclonal antibodies, narrow spectrum antibiotics or microbial transplants that would
have a direct impact in preventing and/or treating this deadly disease.

Public health relevance
PROJECT NARRATIVE One of the reasons that explains the high mortality of pancreatic cancer and the lack of responses to most therapies is the fact that the immune system is inactive around this tumor. In this grant we aim to characterize how gut bacteria can trigger immune responses that maintain an immunosuppressive environment which favors tumor growth and resistance to therapies. We plan to study the mechanisms implicated in these events, which include epithelial regulation of immune checkpoint molecules and recruitment of neutrophils, and to target IL-17 to turn pancreatic cancer into a tumor sensitive to immunotherapy.